Characterization of Interkingdom Synergy between Group B Streptococcus and Candida albicans

PROJECT SUMMARY
Streptococcus agalactiae
microbiota
However,
disease
factor
30%.
or Group B streptococcus (GBS) is a pathobiont that is often part of the normal
found in the gastrointestinal (GI) tract and reproductive tract of healthy people.
it onset
( LOD), which presents as meningitis. Maternal GBS colonization represents the most important r isk
for adverse pregnancy outcomes and neonatal infections, worldwide range from 10-
F
female (FRT)
is a major cause of serious invasive disease in neonates, including pneumonia, sepsis and late
and carriage rates
etal and neonatal infection can occur following i) ascending infection of the placental membranes in utero,
ii) passage through the birth canal, by aspiration of infected vaginal fluids, or iii) colonization of the neonatal GI
tract, which can occur during childbirth, or ingestion of infected breast milk postnatally. The fungus Candida
albicans (Ca) is also a frequent inhabitant of the GI tract and FRT, with asymptomatic carriage rates of
approximately 30% in women, and a higher prevalence often reported with age and in pregnancy. A growing
body of evidence has identified C. albicans as an independent risk factor for vaginal colonization by
GBS. However, surprisingly little is known about the cross-kingdom interactions that govern these bacterial-
fungal associations within the GI and genital tract mucosa. We now have data using our mouse model of vaginal
colonization that indicates co-colonization with Ca increases GBS vaginal persistence in vivo; however, the
specific mechanism(s) for this synergy is unknown. We also show that Ca significantly enhances GBS
attachment to vaginal mucosa using a newly developed multi-layered, highly differentiated human Vaginal
Epithelial Cell-Air Liquid Interface (hVEC-ALI) model. Using triple RNA-sequencing during co-culture we have
observed that Ca reprograms GBS transcription to induce adhesins and 
-hemolysin/cytolysin
(  -h/c) that are
requiredfor GBS colonization and virulence, and that Ca responds to GBS by upregulating genes involved in
arginine biosynthesis and uptake. We hypothesize that a GBS-Ca direct physical interaction promotes this
transcriptional remodeling to promote GBS host cell attachment, vaginal persistence, and ascending infection.
Further, that Ca arginine biosynthesis promotes GBS survival and virulence potential. We will also explore the
hypothesize that Ca will similarly promote GBS neonatal intestinal colonization which could impact LOD, and
that GBS mucosal colonization can be Ca Als3-based vaccine. We
will examine these hypotheses in the following aims: 1) Determine the consequence of Ca-induced
transcriptional reprogramming to GBS vaginal colonization and disease, 2) Elucidate the role of Ca arginine
biosynthesis to GBS-Ca synergy and vaginal persistence, 3) Examine the effect of Ca on GBS intestinal
targeted by therapeutic intervention with a
colonizationand LOD, and the potential for maternal vaccination in preventing cross-kingdom synergy.

Public health relevance
PROJECT NARRATIVE Group gastrointestinal intrauterine B streptococcus (GBS) is a pathobiont that is often part of the normal microbiota found in t he and genital tracts of healthy women; however, d uring pregnancy GBS is a frequent cause of infection that can result in adverse pregnancy outcomes, as well as neonatal infection. A growing body of evidence has identified the fungal pathogen, Candida albicans (Ca), as an independent risk factor for GBS vaginal colonization. This application seeks to elucidate the cross-kingdom interactions that govern the bacterial-fungal associations that lead to GBS vaginal carriage and ascending infection.